Time to ROSC as a Novel Outcome for Pediatric Cardiac Arrest Trials

Project Summary:
Pediatric in-hospital cardiac arrest (p-IHCA) is a devastating medical condition associated with high mortality
and morbidity. While the American Heart Association provides recommendations to guide resuscitation efforts,
most of these are derived from low-quality observational evidence with critical risk for bias. This is because
randomized controlled trials (RCT) for intra-arrest interventions are exceedingly difficult to perform. Given the
critical need for high-quality RCTs to improve outcomes in this field, new trial design techniques must be
developed to help overcome these barriers.
One key element of trial design that may be modified to enhance feasibility is the selection of the primary
outcome. Traditional endpoints for cardiac arrest studies include return of spontaneous circulation (ROSC),
survival to discharge and survival to discharge with favorable neurologic outcome (FNO). However, these
outcomes are all problematic for two reasons. First, the binary nature of these endpoints leads to the need for
very large sample sizes to detect differences in outcomes. This is especially cumbersome in p-IHCA because
not only is it a rare event, but also because the minimal clinically important difference for clinicians treating
cardiac arrest is very small, owing to its high lethality. Second, these outcomes are limited in their ability to
reflect the success or failure of resuscitation efforts. For example, ROSC reflects a successful circulatory
resuscitation, but there is no indication of whether the patient survives to hospital discharge, with or without
FNO. Survival and survival with FNO represent more patient-centered outcomes, but they often do not reflect
the results of the resuscitation in isolation given the vast number of life-limiting disease states associated with
p-IHCA as well as the risk for unrelated complications in the interval between arrest and discharge.
Therefore, we propose to explore the use of Time to ROSC as a novel outcome for pediatric cardiac arrest
studies. Time to ROSC is a critical element in resuscitation as it represents the period of the “low flow”
circulatory state to critical organs including the heart and brain and is strongly associated with survival and
survival with FNO. To develop this outcome, we plan to use a large national pediatric cardiac arrest registry to
perform simulation-based analyses to determine the optimal statistical strategy for patients who do not achieve
ROSC. Following the development phase, we will use data from a recent multicenter trial to evaluate the
performance of Time to ROSC under “real world” conditions. As power is likely to increase with this time-to-
event analysis, this approach has the potential to significantly decrease the number of patients needed to
detect meaningful differences between treatment groups as well as better reflect the direct effects of intra-
arrest interventions, making intra-arrest trials more feasible, informative and cost-effective.

Public health relevance
Project Narrative: Given the dismal outcomes from pediatric cardiac arrest and the dearth of high-quality data in the field, methods to facilitate clinical trials are needed to improve resuscitation efforts. This proposed simulation study aims to explore Time to Return of Spontaneous Circulation (ROSC) as a novel outcome for pediatric cardiac arrest trials with the potential to significantly decrease the number of patients needed to detect meaningful differences between treatment groups as well as better reflect the direct effects of intra-arrest interventions. While this project focuses on pediatric in-hospital cardiac arrest, the resulting principles are likely to be applicable across all cardiac arrest populations, making intra-arrest trials more feasible, informative and cost- effective.